Defining the Role of Matrix-Bound Nanovesicles in Extracellular Matrix Formation and Wound Repair

The extracellular matrix is a critical component of all tissues and required for tissue repair, and discoveries of
elements within this matrix has led to advances in our understanding and development of therapeutics for wound
repair. Of these elements are matrix-bound nanovesicles (MBVs), a newly discovered type of extracellular
vesicle embedded within the extracellular matrix. As a type of extracellular vesicle, MBVs are nanoparticles
secreted by cells that carry unique cargo within a lipid-bilayer decorated with surface markers to directly transport
functional cargo to cells. To date, MBVs have been isolated from decellularized tissues (heart, bladder, intestine,
others) as well as the extracellular matrix produced by cells in vitro. MBVs are distinctly different from other
extracellular vesicle types and have demonstrated cargo enriched in organ and tissue development factors. As
a potentially critical component of the extracellular matrix, and thus wound repair, we seek to explore
fundamental questions regarding MBVs that have yet to be answered: (1) Are MBVs a component of all
extracellular matrices and are MBVs required for extracellular matrix formation? (2) How does MBV cell origin
influence tissue-specific wound repair? To answer these questions, we use 3D collagen biomaterials and human
mesenchymal stem cells to study and replicate human extracellular matrix function and repair. To answer our
first question, we utilize super-resolution microscopy to visualize extracellular matrix production and determine
localization of MBVs to extracellular matrix components. We will also modulate extracellular vesicle production
to determine whether MBV production impacts a cell’s ability to form an extracellular matrix. To answer our
second question, we will isolate MBVs from various cell types and sexes and examine their cargo and role in
stem cell differentiation to determine whether MBV cell origin ultimately changes cell lineage commitment. We
then will design biomaterials patterned with MBVs to examine a cell’s ability to sense different extracellular
vesicle populations in the extracellular matrix. Ultimately, this proposal will improve our understanding of MBVs,
a critically understudied component within the extracellular matrix. In the long-term, answers to these questions
will uncover the importance of MBVs in wound repair and this information can be used to advance wound repair
practices as well as foundational research in how alterations in MBV production may contribute to cancer and
disease. The projects within this proposal will serve as a foundation for my lab’s long-term goals to understand
how MBVs and other EVs influence tissue repair, disease, and homeostasis. Projects within this proposal are
connected to broader goals to engage diverse groups of scientists. We will (1) include and recruit diverse
personnel and perspectives by partnering with existing research training programs on campus, (2) increase
research exposure to underrepresented minorities through community outreach, and (3) enhance student career
opportunities by prioritizing student publications and presentations and organize workshops that intersect Art
and Science to both connect with the local community and train students in science communication.

Public health relevance
Wound repair requires a complex assortment of cellular signals to guide cell function towards successful tissue regeneration, and among these signals is a recently discovered and underexplored nanoparticle embedded in tissues. Due to the novelty of this nanoparticle, termed matrix-bound nanovesicles, we have yet to discover if this nanoparticle is a necessary signaling element for successful wound repair and what variables (sex, cell type) influence matrix-bound nanovesicle activity. This proposal will provide fundamental knowledge of the role these nanoparticles play in tissue formation, and for long-term applications in understanding disease and improving tissue repair.